Physiology of ribosome rescue in bacteria

Project Summary/Abstract
Ribosome rescue pathways are conserved throughout bacteria, but the reason these pathways are important for
physiology is not understood. The long-term goal of this project is to understand the function of ribosome rescue
pathways and to target these pathways for new antibiotics. The overall objective of the proposed project is to
identify interactions among components of the translation machinery that are specifically required for ribosome
rescue and under what conditions different ribosome rescue systems are required. The central hypothesis of this
work is that specific interactions within the ribosome and between the ribosome and other translation factors are
uniquely required for ribosome rescue and that alternative rescue systems are critical under environmental
conditions that cause RNA damage. The rationale for pursuing the proposed research is that it will determine
why ribosome rescue is conserved in bacteria and will enable development of new antibiotics. The central
hypothesis will be tested by pursuing the following specific aims: 1) identify the molecular interactions required
for trans-translation, 2) determine how ArfT rescues ribosomes in conjunction with either RF1 or RF2, and 3)
determine why alternative ribosome rescue systems are required. Published work and preliminary data have
identified small molecule inhibitors of trans-translation, and work in the first funded period of this grant identified
their molecular targets. Biochemical and mutational analyses will be used in Aim 1 to determine why these targets
are important for trans-translation and how the targets are disrupted by inhibitor binding. We will used structural
and biochemical experiments in Aim 2 to determine the mechanism of a new alternative ribosome rescue
pathway, ArfT, that can recruit either RF1 or RF2 to non-stop ribosomes. Our preliminary data identified
conditions where the alternative ribosome rescue factor ArfB is required in Caulobacter crescentus, even when
trans-translation is functional. We will determine the molecular basis for the ArfB requirement and determine of
other alternative ribosome rescue factors are required under similar challenges in other bacteria. The use of
small molecule inhibitors for chemical biology experiments to probe ribosome rescue is highly innovative, and
the work proposed here is significant because it will delineate the physiological requirement for ribosome rescue
pathways in bacteria and identify how these pathways can be inhibited.

Public health relevance
Project Narrative This project will have a significant impact on the fundamental understanding of bacterial physiology by determining why ribosome rescue pathways are essential for bacteria, providing the first structural and biochemical pictures of ribosomal interactions required for ribosome rescue, and providing biochemical and structural information that will allow rational optimization of the activity of ribosome rescue inhibitors. These studies will enable development of ribosome rescue inhibitors as new antibiotics. Therefore, this work will have a large and direct impact on improving human health.